Role of acetyl-CoA metabolism in the response to dietary and thermal stress

PROJECT SUMMARY
Metabolic diseases including non-alcoholic fatty liver disease (NAFLD), type 2 diabetes, and cardiovascular
disease, which are linked to obesity, pose a major threat to economic and healthcare systems worldwide.
Accordingly, there is a great need for new therapeutic targets and strategies. Abnormal lipid metabolism,
especially in the liver, is a hallmark of metabolic disease, and the enzyme ATP-citrate lyase (ACLY), which
generates acetyl-CoA for lipid and cholesterol synthesis, has emerged as a promising therapeutic target against
fatty liver. To this point, several ACLY inhibitors are in development for clinical use, and one that specifically
targets hepatic ACLY has been FDA approved against high cholesterol. However, it is now appreciated that
there are multiple routes to lipogenic acetyl-CoA that are tissue and diet dependent. For example, lipogenic
acetyl-CoA can also be derived from acetate via acetyl-CoA synthetase 2 (ACSS2) in certain dietary contexts,
and emerging data indicates additional pathways to lipogenic acetyl-CoA likely exist. Moreover, work in the last
decade has conclusively shown that lipid homeostasis in humans requires coordination between the body’s
thermal regulatory organs (brown adipose tissue) and its energy storing and distribution centers (the liver and
white adipose tissue), which is corroborated by studies in murine models further indicating that brown fat and
liver and the two most lipogenic organs. The implications of these discoveries are that targeting ACLY
systemically in one tissue or dietary context may be beneficial while targeting it in another may be detrimental.
Indeed, our published and preliminary data supported by this grant show there is considerable interplay between
the ACLY and ACSS2 pathways in brown and white adipose tissues and liver that is both context (i.e. diet and
temperature) dependent and compensatory. Thus, effectively deploying ACLY or ACSS2 inhibitors will require
a much deeper understanding of the tissue, diet, and thermoregulatory dependent mechanisms by which
lipogenic acetyl-CoA is synthesized and utilized in vivo.
In this proposal, we leverage tools and techniques generated in the previous funding period to investigate the
biological functions of ACLY and ACSS2 in thermogenic adipocytes (Aim 1) and hepatocytes (Aim 2). Our
approach utilizes tissue-specific single and double knockout models of ACLY and ACSS2 that we have
generated, and techniques in metabolomics, compartmentalized metabolite analysis, and in vivo stable isotope
tracing that we have adapted for studying adipose tissues and liver. This work will be facilitated by a team of
researchers with complementary expertise and who have collaborated productively for several years. Our long-
term goal is to identify optimal strategies, such as drug/diet combination therapies, to help patients suffering from
metabolic diseases.

Public health relevance
PROJECT NARRATIVE Metabolic diseases associated with abnormal lipid metabolism present massive health and economic burdens worldwide and there is overwhelming demand for new therapies. The enzymes ATP citrate lyase (ACLY) and acetyl-CoA synthetase 2 (ACSS2), which generate acetyl-CoA for lipid synthesis, have emerged as promising targets. However, for such therapies to be maximally effective in the clinic, major gaps must be filled in understanding the interplay between ACLY and ACSS2 pathways and their tissue-specific roles in lipid metabolism, and filling these gaps is the goal of this proposal.